Testing the functional consequences of rapid centromeric DNA and protein evolution

PROJECT SUMMARY/ABSTRACT
The centromere is a network of proteins rooted to centromeric DNA by nucleosomes containing a
centromere-specific histone H3 paralog, CENP-A. Despite the centromere’s conserved role in chromosome
segregation, a subset of its proteins that are essential for its function exhibit molecular signatures of rapid
adaptive evolution. Repetitive centromeric satellite DNA also rapidly evolves, drastically diverging in sequence
between species. The “centromere drive hypothesis” proposes that a genetic conflict between centromeric
DNA and proteins causes their rapid evolution. Specifically, centromeric DNAs behave selfishly and increase
their inheritance through female meiosis (drive) by increasing binding affinity for centromeric proteins. Selfish
centromeres are also detrimental to the organism, which selects for novel centromeric protein variants with a
lower affinity for the selfish DNA, thereby suppressing drive. The centromere drive hypothesis further predicts
that distinct evolutionary lineages undergo unique bouts of centromeric DNA-protein co-evolution, leading to
deleterious centromeric DNA-protein incompatibilities in hybrids that promote reproductive isolation.
I have developed a novel experimental system to test three key propositions of the centromere drive
hypothesis. The first is that centromeric DNA repeat variants differentially recruit centromere proteins. By
fertilizing the eggs of M. musculus with the sperm of divergent Murinae species, I test whether the two species
centromeric DNA repeats differ in their ability to recruit centromeric proteins from the hybrid zygote cytoplasm.
My preliminary data indicate that Mus pahari CENP-A nucleosomes have a higher binding affinity for a key
centromeric protein scaffold, CENP-C, than M. musculus CENP-A nucleosomes. For my first aim, I will
biochemically reconstitute the M. pahari CENP-A nucleosome and test whether the centromeric DNA that
wraps it imparts this increase in CENP-C binding. For my second aim, I will test whether rapidly evolving
centromere protein orthologs (variants) differentially bind to centromere DNA. I will transiently express various
centromere protein orthologs in hybrid zygotes and determine whether their binding preferences for the two
species’ centromeres differ. For my third aim, I will test whether divergent centromere DNAs result in
deleterious incompatibilities in hybrids. I found that in M. musculus / M. pahari hybrid zygotes, a subset of M.
pahari centromeres are mispackaged. I will generate a more contiguous M. pahari genome assembly to
determine if unique M. pahari centromeric DNA sequences underly this mispackaging, and test whether
mispackaging causes deleterious chromosome missegregation.
The hybrid embryo system that I developed serves as a powerful tool to interrogate not only functional
divergence of centromeric DNA and proteins, but also genetic conflict more broadly by uncoupling selfish
DNAs from their species-specific suppressors. This system and my training will position me to establish a
future research program around diverse mammalian selfish genetic elements (see Career Goals).

Public health relevance
PROJECT NARRATIVE Proper segregation of chromosomes during mitosis is essential for genome integrity and cellular viability. Despite chromosome segregation being a fundamental biological process, the DNA and proteins that make up the segregation machinery (i.e. the centromere) rapidly evolve. This proposal studies the functional consequences of rapid centromere evolution on genome integrity during early embryogenesis and how they might contribute to infertility and aneuploidy.